1/2 CCNY-MSKCC Partnership for Cancer Research, Education and Community Outreach

The CCNY-MSKCC Partnership has successfully created a mutually beneficial, cross-institutional collaboration
that has emphasized research across the translational continuum, the creation of an education pipeline for
attracting minority and low-income students to careers in cancer research, and the establishment of community
networks and resources for conducting linguistically and culturally-responsive community engaged research
among diverse, at-risk populations. Over the last five years, areas of particular strength have been developed,
including: 1) rich collaborations between engineers and computer scientists at CCNY and clinicians and imaging
experts at MSKCC to develop innovative solutions to improve cancer care, and 2) sustainable, translational
health disparities research and activities that directly benefit underserved communities in New York, and serve
as national models in terms of: a) screening / identification of cancer risk factors that disproportionately affect
minorities; b) socioeconomic determinants of access to, and successful completion of, treatment; and c) policy
change. Consistent with these areas of emphases, we propose two full projects that focus on: 1) Tumor
ensemble models to predict tumor dormancy and reactivation and testing how these models perform across
various ethnic cell lines, e.g., triple negative tumors that disproportionately affect African American women and
2) Characterizing the Role of ATM in Immunoglobulin Gene Diversification and Genome Stability. Two proposed
pilot projects include: 1) Raman spectroscopy with heavy water labeling and multiphoton microscopy to allow
early detection of breast cancer subtypes, including triple negative cancers and 2) Development of Mechanical
Interventions to Enhance Drug Delivery to Bone Tumors. New innovative Partnership components include: 1)
development of the Linguistic and Cultural Responsiveness Shared Resource Core; 2) formation of the
Engineering Health Disparities working group; and 3) new educational programs including the Scholars for the
Future program and the Certificate for Medical Translation and Interpretation. The Partnership specific aims are
to: 1) Continue to develop outstanding cancer research programs in health disparities, biomedical
engineering, computer science / medical imaging, cancer cell biology, and immunology along the
Translational Research Continuum; 2) collaborate with diverse communities to conduct and facilitate trailblazing
cancer disparities research, and outreach, education, risk reduction, and navigation activities to define and
address cancer disparities, with the goal of improving cancer care in the large, medically underserved local and
national communities; 3) continue to develop and expand educational opportunities in a robust translational
cancer research environment to attract and retain students interested in cancer research (particularly minority
and low income students); these opportunities will be enhanced by educational opportunities and increased
mentorship and support; and 4) expand and integrate the personnel, resources, and environment needed for
scientific collaboration across institutions and influence institutional policies in support of this objective.

Public health relevance
Narrative This proposal describes our plans to continue and enhance the City College of New York - Memorial Sloan Kettering Cancer Center Partnership for Cancer Research, Education and Community Outreach. The CCNY- MSKCC Partnership is a mutually beneficial, cross-institutional collaboration that has promoted translational research, created an education pipeline for minority and low-income students to advance in cancer research careers, and has established community networks and resources for conducting culturally-responsive community engaged research among diverse, at-risk populations in the New York area.